SHCC MU NCORP

DESCRIPTION (provided by applicant): John H. Stroger Jr, Hospital of Cook County (SHCC) in Chicago, Illinois is the major tertiary care site for the Cook County Health and Hospital System (CCHHS). The majority of cancer cases are from minority-underserved populations, and are predominantly African American. SHCC plans to develop, strengthen and improve coordinated care and clinical research through the implementation of the NCI Community Oncology Research Program (NCORP). Dr. Thomas E. Lad will continue as Principal Investigator (PI). The SHCC NCORP will maintain and nurture relationships with cancer research bases formed under the MBCCOP program to facilitate broad and improved participation in treatment and prevention/control trials for breast, lung, prostate, gastrointestinl, brain, hematologic, head and neck, and gynecologic cancers; increase scientific activity at the research base level by initiating and chairing an ECOG group-wide cancer control/CCDR study concerning reproductive issues of female cancer patients; increase support for oncologists and other cancer related healthcare providers; encourage multidisciplinary cancer care and integrated research; facilitate transfer of state-of-the-art quality oncology care and new technology to minority-underserved populations in their own communities through participation in NCI-approved clinical trials; focus on prevention and control as methods for reducing cancer incidence, morbidity and mortality; expand our clinical trial menu to include Cancer Care Delivery Research though access to the Chicago Area Patient Centered Outcomes Research Network (CAPriCORN) data base which is supported by a large PCORI grant; and extend and promote research involvement and opportunities with emphasis on the particular needs of the community served, promoting outreach and education.

Public health relevance
RELEVANCE (See instructions): The implementation of the NCI Community Oncology Research Program at SHCC in Chicago is imperative to continue the availability of oncologic clinical trials to the minority-underserved patients of Cook County.